SAFETY OF GAMMAGARD IGIV GIVEN AT INCREASED RATES

The purpose of this study is to evaluate the safety of Gammagard IGIV (human immunoglobulin) given either in increased concentration or increased rate of infusion in patients with a primary immunodeficiency syndrome. This will be done as part of a multicenter, nonrandomized trial. Each patient will receive a dose of 400 mg/kg once each month.